Center for 3D Structure and Physics of the Genome

Summary/Abstract
For quality, interpretation, reproducibility, and sharing value, microscopy images should be accompanied by
detailed descriptions of the conditions that were used to produce them. The NIH-funded 4D Nucleome (4DN)
Imaging Standards Working Group (IWG), working in close collaboration with the BioImaging North America
(BINA) Quality-Control and Data Management Working Group (QC-DM-WG), has recently published a tiered
system of extensions of the existing Open Microscopy Environment (OME) Microscopy Metadata model for
microscope hardware specifications, image acquisition setting, and quality-control metrics. The model
provides a clear set of OME-model-compatible recommendations guiding scientists in the 4DN community
and beyond as to what metadata and calibration results should be provided to ensure the reproducibility of
different categories of imaging experiments. Because the tremendous challenges require concerted global
action, national organizations such as BINA, Canada BioImaging (CBI/BIC), and German BioImaging have
recently joined forces with individual imaging scientists from both academia and industry to establish the
QUality Assessment and REProducibility in Light Microscopy (QUAREP-LiMi) initiative as a forum for
building broad consensus on quality control, reporting, reproducibility and sharing value for microscopy
experiments.
Despite these advances, the broader impact of this work crucially depends on how easily biological scientists
working at the bench will be able to adopt the proposed specifications and incorporate them into their
everyday work regardless of imaging expertise. To meet these goals, in close collaboration with the 4DN
Data Coordination and Integration Center (DCIC), we have developed the Micro-Meta App and integrated it in
the 4DN-Data Portal. Micro-Meta App is an intuitive, highly interoperable, open-source software tool designed
to substantially lower the burden of documentation and quality assurance for light microscopy.
Since then, we have made significant progress toward understanding the opportunities and challenges
involved with the production of high-quality, well-documented, reproducible, and reusable imaging datasets.
In this proposal, we plan to leverage these “lessons learned” and request funds to continue this work and
produce the following deliverables:
1. Develop semi-automated processes for capturing 4DN-BINA-OME-QUAREP specified Microscopy
Metadata about three key HuBMAP imaging assay types, CO-Detection by IndEXing (CODEX),
CellDive and stained microscopy (H&E and PAS) and making available to HuBMAP data generators
and users of the HuBMAP data portal.
2. Develop W3C-compatible JSON-LD file formats to be incorporated into the OME-Next Generation
File Format (NGFF) and facilitate metadata exchange across different communities.

Public health relevance
Narrative To enhance the quality, interpretability, reproducibility, and shareability of microscopy images, it is crucial to include comprehensive descriptions of the experimental conditions used to produce them. Hence, the adequate documentation of imaging data is highly dependent on the ease with which biological researchers can adopt and implement community recommendations in their daily work, irrespective of their proficiency in imaging techniques. The goal of our proposal is to further advance the accessibility of user-friendly tools developed collaboratively by the 4D Nucleome Network and integrate them seamlessly into the HuBMAP data portal. This will empower HuBMAP investigators to produce high-quality microscopy datasets with the potential for maximal reusability and broader community impact.